TMJ-on-a-chip for delineating multi-tissue crosstalk in inflammation and pathophysiological mechanical loadings

Project summary
Over 80% of symptomatic temporomandibular joint disorders (TMJD) patients have a TMJ disc displacement,
linked with osteoarthritis (OA). The abnormal jaw mechanics involved with TMJ disc displacement can lead to
disc thinning and perforation, frequently progressing into OA. In the last decade, we and others have actively
explored regenerative approaches for severely damaged TMJ discs with some promising pre-clinical outcomes.
However, the regenerative strategies for TMJ disc should be evaluated considering the abnormal joint mechanics
and inflammation caused by joint trauma or disc displacement. In addition, TMJ is a multi-tissue organ where
multiple tissues, including cartilage, bone, TMJ discs, synovium, ligaments, and surrounding fat, are believed to
interact with each other for joint function, homeostasis, disease initiation, and progress. Unfortunately, we have
an extremely limited understanding of multi-tissue crosstalk in TMJ, linked with a paucity of reliable experimental
models. The objective of this proposal is to develop and validate a patient-specific TMJ-on-a-chip (TMJoC) model
for investigating multi-tissue crosstalk regulating TMJ disc injury and healing under inflammation and
pathophysiological mechanical stimulation. Our team has extensive experience in joint-on-a-chip (JoC) for multi-
tissue interactions in the knee joint during meniscus injury and healing. Based on the expertise, we have
developed a TMJoC integrated into a novel TMJ disc-specific bioreactor, consisting of i) a joint cavity where
discs are cultured and physio/chemically stimulated, ii) bioprinted synovial membrane layered with lining
macrophages and synovial mesenchymal stem/progenitor cells (MSCs), iii) tissue-engineered ligaments, iv)
engineered osteochondral tissues and v) MSCs-derived adipose tissues. Gene expression profiles of the
engineered tissues were validated using RNA-seq data from human tissues. Tissue compartments were
separated by semi-permeable membranes, and under-layered microfluidic channels supply tissue-specific media.
Mechanical loading units replicating patient-specific condyle and fossa anatomy are integrated to apply
physiological loading to TMJ discs in the TMJoC via 3-axis micro-precise motion controllers. Our preliminary
data suggest that the healing of TMJ disc perforation by our well-established bioactive glue was interfered with
IL-1β, and physiological loading attenuates the harmful effect of IL-1β. Interactions with synovium further
hampered disc healing with elevated pro-inflammatory cytokines, mitigated by an existence of adipose tissue.
scRNA-seq with CellChat analysis suggested robust communications between adipocytes, MSCs, and
macrophages in discs healing, highlighting fat's notable metabolic and anti-inflammatory functions. As supported
by solid preliminary data, we aim to 1) determine the roles of multi-tissue crosstalk in TMJ under inflammation
and pathophysiological mechanical loadings and 2) establish a patient-specific TMJoC from human iPSCs. The
proposed TMJoC, as a patient-specific platform, has a wide range of research applications, including TMJ
homeostasis, metabolism, biology of disease initiation and progress.

Public health relevance
Project narrative Multi-tissue crosstalk in temporomandibular joint (TMJ) is believed to play roles in joint homeostasis, function, disease initiation and progress. However, we have extremely limited understanding of the multi-tissue crosstalk in TMJ, as associated with a paucity of reliable research models. Studies in this proposal are anticipated to develop and validate a novel TMJ-on-a-chip to delineate the roles of multi-tissue crosstalk in TMJ.